Mechanisms of Junctional Proteins in Post-Surgical Lymphedema

Project Summary
Lymphedema is chronic limb swelling from lymphatic dysfunction which affects 250 million people worldwide. It
is estimated that 5-10 million Americans have lymphedema. Primary lymphedema is rare and results from errors
in lymphatic development. Secondary lymphedema accounts for 99% of the condition and occurs most
commonly following surgical management of solid tumors (e.g., breast cancer, melanoma). Axillary lymph node
dissection results in lymphedema in 30% of patients post-operatively. Skin thickening, interstitial fluid retention,
and fibroadipose subcutaneous deposition from inflammation result in progressive limb enlargement.
Lymphedema impacts quality of life and has a high health cost burden. Morbidity includes recurrent cellulitis,
pain, and impaired extremity function. Non-surgical management of lymphedema includes compression therapy.
Surgical treatment involves excisional (e.g, skin/subcutaneous resection) and microsurgical physiologic
procedures including vascularized lymph node transfer and lymphovenous bypass. Current treatments may
variably improve limb size, but do not cure lymphedema.
Lymphatic capillaries develop discontinuous button-like junctional proteins which facilitate absorption of
interstitial fluid into lymphatics at the capillary level. Continuous zipper-like junctional proteins are present in
lymphatics which transport lymph without leakage. Rare genetic causes of primary lymphedema affect initial
lymphatic capillary button junction development resulting in zippers instead of buttons. In the lung, chronic pleural
inflammation has been found to result in the replacement of button junctions in pleural lymphatics with zipper
junctions leading to impaired drainage function and pleural effusion. Secondary lymphedema occurs on an
average of one year post-operatively following surgical lymph node dissection indicating the etiology of
lymphedema is not only the mechanical disruption of lymphatics. Following post-surgical lymphatic injury,
activation and maintenance of chronic inflammation is critical in the development of lymphedema. The goal of
this application is to understand the mechanism and pathophysiology of junctional protein changes in secondary
lymphedema. This will inform us about the fundamental underlying etiology of lymphatic stasis in lymphedema
and, importantly, help us develop targeted therapies to improve the lives of patients with lymphedema. We
hypothesize that inflammation after lymphatic injury results in capillary lymphatic button junction changes to
impermeable zipper junctions rendering interstitial fluid uptake inefficient. In Aim 1, we elucidate how lymphatic
injury affects lymphatic junctional proteins in secondary lymphedema. In Aim 2, we determine the effects gene
delivery targeting junctional protein pathways following lymphatic injury. Our approach uses a combination of
mouse models and clinical specimen to have a high translational significance.

Public health relevance
Project Narrative Lymphedema is a morbid condition with limb enlargement that frequently occurs after lymph node removal in the treatment of breast cancer. It affects 5 million Americans. This study investigates the role of junctional proteins in post-surgical lymphedema and novel approaches targeting these junctional proteins to prevent lymphedema.